Regulation of diurnal rhythms in parvalbumin and perineuronal net function

Abstract
Memory retrieval requires optimal functioning for an organism’s survival and varies with the time of day. The
biological clock biases output of brain circuitry to coordinate behaviors across the light/dark cycle. GABAergic
neurons align circuit activity to gate daily rhythms through expression of local circadian-associated clock
genes. Parvalbumin (PV) GABAergic neurons powerfully modify circuits needed for memory retrieval, but the
extent to which PV neurons regulate daily rhythms in retrieval is unknown. This information is important
because desynchrony between the 24 hr light cycle and endogenous circadian rhythms leads to cognitive
deficits in shift workers, those with jet lag, aged individuals, and in those with neurological disorders in which
circadian regulation of the biological clock is impaired. In the medial prefrontal cortex (mPFC), the focus of
these studies, most PV neurons are enwrapped in structures called perineuronal nets (PNNs), which restrict
plasticity in adulthood and are vital for precise firing of PV neurons. We discovered that the expression of
PNNs and PV exhibit a diurnal pattern in the rat mPFC, and propose that this diurnal pattern is a major factor
driving diurnal differences in memory retrieval. Moreover, we propose that the diurnal pattern in PNNs is
coordinated by orthodenticle homeobox 2 (OTX2), which maintains PNNs and exhibits a similar diurnal pattern
as PNNs. OTX2 appears to bind to promoter-proximal regions of the clock genes Clock, Per1, and Per2 and
thus may serve as a major integrator of activity-dependent rhythms that coordinate with these clock proteins.
Consistent with this, we show that PNN removal disrupts the diurnal rhythm of PER1 protein levels in PV
neurons. Together, prior work and our studies show that PNNs influence the core clock, which can potently
influence circuit function during memory retrieval. We hypothesize that PNNs surrounding PV neurons in the
mPFC are a major contributor to diurnal patterns of memory retrieval through regulation of clock genes. Our
studies will define how diurnal fluctuations in PNNs around PV neurons alter circadian genes and PV neuron
function in the mPFC, and whether these diurnal fluctuations underlie diurnal differences in memory retrieval.
Conversely, we will determine how manipulation of the clock gene Bmal1 alters PNNs, PV neuron function,
and memory retrieval. We will use behavior, innovative molecular approaches, and in vitro and in vivo
electrophysiology to address the following three Specific Aims: Aim 1) Determine how PNNs in the mPFC
modulate rhythmicity of PV neuron clock genes, PV neuron function, and memory retrieval.; Aim 2)
Determine whether the core clock in mPFC PV neurons regulates rhythmicity of PNN, PV neuron
function, and memory retrieval; and Aim 3) Define diurnal changes in oscillatory communication
between the mPFC, basolateral amygdala, and hippocampus. Understanding how endogenous daily
rhythms in PNNs and their PV interneurons contribute to memory retrieval is expected to facilitate treatment of
cognitive impairments in those with circadian rhythm desynchrony.

Public health relevance
PROJECT NARRATIVE Circadian rhythms powerfully regulate our daily physiological and mental functions, but these rhythms can be disrupted in shift work, during jet lag, during ageing, and in individuals with a wide variety of neurological disorders. Individuals with these conditions experience cognitive impairment. Our studies focus on neural mechanisms in the prefrontal cortex that we believe contribute to this impairment during disruption of daily rhythms. These studies have translational potential in humans because impaired cognition can be debilitating for those with altered sleep/activity rhythms and for those with disorders linked to dysregulation of biological timing mechanisms.